The cholinergic system during normal and pathological aging

We have now begun to have mice at the NIH to study and to generate data in the lab as well as to establish new collaborations at NIH (specifically with Drs Innis and Reich). Our studies employ behavioral, high resolution live imaging, in vivo and ex vivo electrophysiological assays of cognitive function with an emphasis on changes in cholinergic modulation of entorhinal cortex and ventral subicular circuits. Some aspects of the Aging project also involved continued collaboration with individuals at Universities that were operational and as such, we were have one manuscript in press that relates to this project. Two major publications on comparative studies of mouse and humans with cognitive decline are still in preparation.